Admin supp: Metalloenzymes and metal homeostasis

Project Summary
The goal of this administrative supplement request is to maintain and improve the cultivation of methanotrophic
bacteria for production of particulate methane monooxygenase (pMMO) and methanobactins. All aspects of this
research program require fermentation of methanotrophs. The proposed equipment will add significant new
fermentation capabilities.

Public health relevance
Project Narrative Methane gas is a major contributor to climate change, which represents a significant threat to human health. Methane-consuming bacteria have the potential to mitigate methane emissions and also produce copper-binding natural products with promising therapeutic applications. This equipment will be used to grow these bacteria in the laboratory for chemical and biological studies.